Engineered Antimicrobial Platform to Target Pulmonary Intracellular Infections

PROJECT SUMMARY/ABSTRACT
Intracellular infections based in the lung alveolar macrophage population remain one of the most challenging
anti-infective settings and unmet medical needs. Diseases such as tuberculosis, legionellosis, tularemia and
melioidosis cause high mortality and morbidity costs around the globe. The long-term goal of this project is to
develop and validate a new inhalable macromolecular therapeutic platform termed “drugamers” that targets
antibiotics and antibiotic drug combinations to the alveolar macrophage to better treat lung-based intracellular
infections. A key new property of this platform, that currently does not exist in clinically available therapeutics
and delivery systems, is the ability to engineer custom tailored pharmacokinetic (PK) drug release profiles in
the alveolar compartment and targeted alveolar macrophages that match the required PK profiles of specific
antibiotic classes and specific bacterial infection processes. To achieve this objective, the project brings
together a multi-disciplinary team across polymer therapeutics, glycan targeting of alveolar macrophages, and
clinical expertise in alveolar-based bacterial pathology and treatment. The initial therapeutic focus is on
tularemia and melioidosis, with clinical investigators and access to BSL-3 human pathogen models and
facilities. The proposal is structured around 4 specific aims to: (1) Synthetically construct mannose-targeted
drugamers of fluoroquinolone, β-lactam, and aminoglycoside drugs and drug combinations with controlled
release profiles and architectural morphologies designed to optimize alveolar macrophage uptake. (2) Optimize
the biocompatibility, alveolar macrophage targeting, and PK properties - measured by liquid chromatography –
mass spectrometry analysis - of the drugamer library in murine models based on known drug dosing profiles of
these major classes of antibiotics. Select optimized drugamers based on these in vivo properties to carry
forward into the surrogate models of tularemia and melioidosis of the next aim. (3) Evaluate in vivo bactericidal
efficacy of the mannose-targeted drugamers selected through their winning properties in Aim 2. Drugamers
administered by aerosoloization will be tested for their ability to achieve cures in highly lethal mouse disease
models infected by controlled aerosolization of surrogate Francisella and Burholderia bacteria. (4) Highly
effective drugamer designs selected in Aim 3 will be assessed in human pathogen mouse models using
Francisella tularensis and Burkholderia pseudomallei at the University of Washington BSL3 select agent
facility. If successful, this project will identify lead inhalation therapeutics for future clinical pathway
development against tularemia and melioidosis. Because the drugamer platform is modular, it could also be
developed against other unmet intracellular lung infection therapy needs, where the growing issue of drug
resistance provides a compelling need for the tailored and combination dosing profiles of this platform.

Public health relevance
PROJECT NARRATIVE Lung infections remain a major public health challenge across the developed and developing world, with diseases such as tuberculosis and melioidosis causing high mortality and morbidity. Effective antibiotic treatment to combat intracellular lung infections remains an unmet need, and the well documented emergence of drug resistance, combined with the different dosing requirements of individual antibiotics, creates a need to target combination drugs to alveolar macrophages with carefully tailored release profiles. The overarching goal of this proposal is to develop a macromolecular therapeutic platform that meets these significant areas of need in global health using advanced polymer chemistry and molecular engineering. !